Multi-Level Risk of Polysubstance use Trajectory and Leveraging Machine Learning Approaches to Detect Overdose Risk

PROJECT SUMMARY/ABSTRACT
Significance. Recent national drug-involved overdose death data has shown that the current opioid epidemic
is characterized by four salient waves that claimed over 106,000 lives in 2021 alone. The current fourth wave
of the epidemic is characterized as an opioid-stimulant polysubstance use. However, it is still unclear how
individuals transition through different substance use profiles, the individual and structural determinants that
are associated with these transitions, and polysubstance use profiles that are at increased risk of overdose.
Additionally, no study to date has used a multilevel approach to develop a machine learning risk prediction
model to predict overdose risk. Career Development Plan. Dr. Cadet’s training program will include seminars,
workshops, coursework, and conferences to develop her skills and expertise in Multilevel Latent Markov
Modeling, Bayesian Inference, longitudinal causal modeling, and in machine learning risk prediction modeling,
which are necessary for conducting her proposed research plan and achieving her career goals of becoming
an independent substance use epidemiology scientist who conducts large observational studies that will inform
the targeted public health intervention and polysubstance use related overdose prevention. Mentorship. A
highly accomplished team of mentors (Drs. Martins, Musci, Stingone, Tabb, Aiello) who are experts in
substance use epidemiology, Bayesian Inference, longitudinal structural equation modeling, biostatistics, and
machine learning, will support Dr. Cadet’s research and training goals. Research Plan. Dr. Cadet will conduct
a multilevel epidemiological study informed by the Risk Environment Model that leverages the size and scope
of the National Longitudinal Study of Adolescent to Adult Health (Add Health) from 1994-2026 (N> 20,000
participants) to answer the following aims: 1) Examine the dynamic transitions across substance use patterns
using Multilevel Latent Markov Models (Latent Transition Analysis) among people who used drugs enrolled in
the Add Health study; 2) Examine whether polysubstance use typologies have poorer survival risk of fatal
overdose by using latent class modeling with a time-to-event distal outcome joint-model approach to explore
latent polysubstance use classes with higher risk of fatal overdose and all-cause mortality in the Add Health
study; 3) Develop a multilevel machine learning algorithms using a train-test split procedure to predict people
who use drugs (PWUD) who are at increased risk of overdose episode by using micro-level (e.g., behavioral,
psychosocial) and macro-level (e.g., area deprivation) factors in the Add Health study. Findings from this study
will inform an R01 to lead a mixed-methods approach to better understand the nuances between intentional
polysubstance use and treatment implications. Public Health Impact. The cross-disciplinary methodologies
such as combining structural equation modeling, Bayesian modeling, and data science is crucial for addressing
the multifaceted challenges of polysubstance use effectively.

Public health relevance
PROJECT NARRATIVE Polysubstance use is leading the current wave of the overdose epidemic, therefore, by identifying distinct patterns and transitions in substance use over time, public health professionals can tailor interventions to specific risk profiles and critical transition points, thereby enhancing the effectiveness of prevention and treatment strategies. Latent transition analysis (LTA) of polysubstance use, combined with survival risk assessments and machine learning predictive models for overdose risk, offers a powerful framework for understanding and intervening in the complexities of the polysubstance use epidemic. Furthermore, integrating advanced machine learning techniques enhances the accuracy and timeliness of overdose risk predictions, enabling proactive, data- driven responses that can save lives and reduce the broader societal impacts of substance misuse.